Center for American Indian and Rural Health Equity

Project Summary The COVID-19 pandemic has disproportionately affected American Indian (AI) and Latino communities, and these groups also have increased risk of poor prognosis due to high rates of chronic disease such as diabetes, cardiovascular disease, and cancer. In the northwestern United States, AI and Latino communities already face significant disparities in health care access, which have been further exacerbated by the COVID-19 pandemic. In the proposed study, Protecting Our Community: A Pragmatic Randomized Trial of Home-Based COVID Testing with American Indian and Latino Communities, we will leverage our long-term community- based participatory research partnerships to test the hypothesis that home-based testing will be feasible, impactful, and better-accepted using active delivery of test kits by trusted community health educators in two vulnerable, high-risk rural communities. Our two long-term partner communities are the Flathead Indian Reservation of the Confederated Salish and Kootenai Tribes in Montana, and the Yakima Valley of Washington, a large Latino community. We will determine the cultural, social, behavioral, and economic barriers to home-based SARS-CoV-2 testing; culturally adapt and enhance home-testing educational materials and create home-testing instructional graphics and YouTube videos; conduct a 2-arm pragmatic randomized trial of active (delivered by community health educator) vs. passive (mailed) home-based testing kits (n = 200/community) for testing completion; and create model community-driven testing protocols that can have significant impact for increasing home-based testing uptake among AI and Latino communities nationally. This work will enable underserved AI and Latino communities to take full advantage of the coming wave of rapid point-of-care home tests and decrease the significant impact of COVID-19 in their communities.

Public health relevance
Project Narrative Working with our Latino community partners in the Yakima Valley, Washington, and our American Indian community partners on the Flathead Reservation in Montana, we will: 1) determine the cultural, social, behavioral, and economic barriers to home-based SARS-CoV-2 testing; 2) culturally adapt and enhance home-testing educational materials; and 3) conduct a pragmatic randomized trial of home- based testing completion between active (delivered by community health educator) vs. passive (mailed) kit delivery. We will then create model community-driven testing protocols for increasing home-based testing uptake among AI and Latino communities nationally. This work will enable underserved AI and Latino communities to take full advantage of the coming wave of rapid point-of- care home tests and decrease the significant impact of COVID-19 in their communities.